Restoring Tolerance with an Oral AMPK Agonist Nanomedicine Targeting Intestinal Dendritic Cells as a Preventative Therapy for Type 1 Diabetes

PROJECT SUMMARY
In the United States alone, an estimated 1.45 million people suffer from Type 1 Diabetes (T1D), a chronic
autoimmune disease resulting from immune-mediated destruction of insulin- producing pancreatic b cells.
Autoimmune recognition of b cells leads to significant loss of b cell mass, resulting in impaired control of blood
glucose levels and hyperglycemia. Standard care involves continuous blood glucose monitoring and daily insulin
replacement. However, the life expectancy of T1D patients is reduced by ~ 20 years compared to the general
population, highlighting an urgent need to develop novel therapies that prevent b cell destruction.
A long pre-clinical period marked by the appearance of immunological abnormalities, including functional loss of
intestinal homeostasis, precedes disease onset in T1D mouse models and patients. A failure to develop
immunological tolerance is centered around a reduced number and function of tolerogenic dendritic cells (tolDCs)
in the small intestinal mucosa, which are critical to the maintenance of GI homeostasis by promoting regulatory
T cell (Treg) induction. Although aberrant APC activity is critical for T1D pathogenesis, there have been no DC-
targeted therapies developed to date for the treatment of T1D. Qrono Inc is developing QR402, a first-in-class,
oral, DC-specific AMPK pathway agonist as a preventative therapy for T1D. QR402 uses custom nanoparticles
to directly promote an AMPK-induced tolDC phenotype. This work is inspired by studies demonstrating 1) that
the AMPK pathway is downregulated by intestinal DCs in T1D patients and 2) that activation of the AMPK
pathway via systemic administration of AMPK pathway agonists can successfully alleviate disease severity in
preclinical mouse studies. While AMPK has long been a target of interest for T1D, clinical development of AMPK
agonists has been limited by severe adverse effects associated with systemic administration including metabolic
complications (i.e. lactic acidosis) and cardiac hypertrophy. Thus, approaches like the ones proposed herein
capable of targeting AMPK agonists to intestinal DCs are vital to safely activating the AMPK pathway that’s
dampened in T1D, and restoring tolerance. Our preliminary data identify the AMPK agonist PF-739 as having
tolerogenic activity, marked by a dampening of pro-inflammatory IL-12p70 production coupled with a significant
increase in anti-inflammatory IL-10 secretion in LPS stimulated DCs, features that promote Treg induction. We
hypothesize that a treatment targeting AMPK-activating compounds to intestinal DCs will restore
intestinal tolerance and protect against T1D onset. Accordingly, we will prepare and characterize enteric-
coated nanoparticles of PF-739 (QR402) that we can then use for the proposed in vitro and in vivo studies.
Successful completion of this project will establish proof-of-concept for a first-in-class DC-targeted preventative
therapy for T1D. Data will be leveraged to support a Phase II STTR to prepare QR402 for clinical translation by
evaluating efficacy in the spontaneous NOD mouse model of T1D, and attract private investment. Qrono will
then develop QR402 through IND-enabling studies to prepare for future clinical trials in T1D- susceptible patients.

Public health relevance
PROJECT NARRATIVE A breakdown in intestinal tolerance mediated by a reduced number and function of tolerogenic dendritic cells (tolDCs) precedes the onset of symptomatic disease during Type 1 Diabetes (T1D). This proposal seeks to test whether QR402, a DC-targeted AMPK agonist designed to restore tolDCs in the GI tract, can restore intestinal tolerance and prevent disease onset in proof-of-concept in vitro and in vivo models of T1D. Successful completion of the proposed project will result in the validation and development of a first-in-class, oral, DC- specific nanotherapy, which could provide a much-needed preventative treatment option for T1D-susceptible patients.